TRIMETHOPRIM-SULFAMETHOXAZOLE VS. AEROSOLIZED PENTAMIDINE IN AIDS PATIENTS

This study is designed to determine the safety and efficacy of trimethoprim sulfamethoxazole plus AZT versus aerosolized pentamidine plus AZT in preventing recurrent pneumocystis carinii pneumonia and extending survival in AIDS patients.